Multilevel Determinants of Breast Cancer: Translating Research into Interventions

DESCRIPTION (provided by applicant): Eliminating cancer health disparities remains a high priority of the National Cancer Institute, and one of the most promising avenues for reducing the burden of cancer. Our nation's investment in cancer research has contributed to many breakthroughs in our knowledge of biomedical and behavioral risk factors. However, to effectively intervene on these risk factors, we must also understand the social contexts within which individual risks are developed and lead to persistent cancer health disparities. My goal in seeking this career development award is to become an independent researcher in the field of cancer health disparities, with a focus on multilevel research and intervention in racial/ethnic minority and socioeconomically disadvantaged communities. To leverage my existing training in social science research and cancer epidemiology, I propose additional training in applied intermediate marker and biomarker research, cancer prevention and control, community-engaged intervention research, and advanced statistical methods. An experienced interdisciplinary team of mentors will provide the necessary and complementary expertise and mentorship. My proposed research will examine the associations of social network characteristics (social integration, social support) and the metabolic syndrome (clustering of high blood glucose level, dyslipidemia, high blood pressure, abdominal obesity) with breast cancer risk and with mammographic breast density, a strong biomarker of breast cancer risk. I will investigate these aims in two separate study populations of Hispanic, African American, and White women, recruited from a socioeconomically disadvantaged community in New York City. I will build on extensive interview, clinical and biomarker data already available for these studies by obtaining the following data: neighborhood social environment (from U.S. Census data and previously constructed built environment data), breast density (measured from routine mammograms using validated computer-assisted methods) and breast cancer diagnosis (through review of medical and pathology records). Based on these results and in partnership with community representatives, I will conduct formative qualitative and quantitative research to guide the development of multilevel intervention strategies for breast cancer risk reduction. Together, these research activities will increase my understanding of the social environment characteristics, mediating behavioral factors, and biological pathways associated with breast cancer risk and increase my skills in community-engaged research and intervention development. Ultimately, this program of research will be applied to prevention of breast cancer risk through community-based interventions in low socioeconomic, racial/ethnic minority communities.

Public health relevance
PUBLIC HEALTH RELEVANCE: This research addresses social, behavioral and biological determinants of breast cancer risk and mammographic breast density in Hispanic, African American and White women of lower socioeconomic status. The results will have high translational potential for reducing breast cancer disparities by identifying individual and contextual level targets for multilevel community-based intervention efforts. __SpecificAimsTextDelimiter__ SPECIFIC AIMS Great strides have been made in identifying many biomedical and behavioral risk factors for breast cancer. However, intervening on these factors at the individual level alone has resulted in limited success and/or short- term gains that have been difficult to sustain (e.g., weight loss/control).20, 21 One reason for the failure to translate research on individual -level risk factors into effective intervention is a lack of understanding of the social contextual factors that shape individual level risk factors. Social networks are key aspects of the social environment. They include the web of relationships that connects individuals to one another and integrates them into the larger social structure (social integration), and the resources that are provided by social network members (social support). The evidence for social network influences on behavioral risk factors for breast cancer (e.g., obesity, physical activity) has been accumulating.22-26 Furthermore, emergent but separate bodies of research link metabolic disorders to breast cancer risk,27-29 and to social network features.30-34 However, these associations and pathways have not been examined together, and their application for breast cancer prevention efforts remains largely unexplored. Here, I will test the hypothesis that poor social support and limited social connections are associated with increased breast cancer risk, and that these associations are in part mediated by behavioral risk factors and related metabolic abnormalities (e.g., abdominal obesity, high blood glucose, dyslipidemia, high blood pressure and their clustering, as defined by the metabolic syndrome). This research will draw on two large cohorts of adult residents of the Northern Manhattan community in New York City, a multiethnic and predominantly low socioeconomic community with a high prevalence of metabolic disorders and high breast cancer mortality. In addition to using extensive epidemiologic, clinical and biomarker data already collected for these cohorts, I will lead the collection of the following data not currently being collected: 1) neighborhood level social environment data, 2) medical and pathology reports for breast cancer ascertainment; 3) mammograms for breast density assessment, and 4) focus group and community survey data. Study 1 (Years 1-2) is a nested case-control study within a prospective population-based cohort of 3,298 community residents (2,077 females) who were enrolled in 1993-2001 and have been followed annually for a median of 8 years35-37 (260 breast cancer cases, 520 controls; 1:2 matched on age, time since follow-up, race). Aim 1.1: Investigate the associations of social integration and social support with breast cancer risk Aim 1.2: Investigate whether the metabolic syndrome (clustering of abdominal obesity, high levels of glucose and triglycerides, low HDL-cholesterol, hypertension) is associated with breast cancer risk and mediates the associations of social integration and social support with breast cancer risk Study 2 (Years 2-4) will extend the above aims by investigating whether the identified social and biological risk factors are also associated with breast density, a strong and potentially modifiable biomarker of breast cancer risk. I will build on available data for a cohort of 1,400 (~840 females) community residents by collecting mammograms for assessment of breast density (n=440 with mammograms). Aim 2.1: Investigate the associations of social integration and social support with breast density Aim 2.2: Investigate whether the metabolic syndrome is associated with breast density and mediates the associations of social integration and social support with breast density Study 3 (Years 3-5) will build upon an academic-community partnership to develop multilevel intervention strategies for future funding applications. The data collected will include focus groups and community surveys, which will be carried out through an iterative process with participation from community representatives. Aim 3.1: Investigate social network and neighborhood level barriers and facilitators for reducing breast cancer risk factors and biomarkers (through focus group and community survey data) Aim 3.2: Identify intervention strategies that target multiple levels of change for reducing breast cancer risk in socioeconomically disadvantaged and minority communities (as informed by proposed research and input from community partners) This research will contribute to breast cancer prevention by providing critical information on: 1) breast cancer risk factors operating at multiple levels of influence, ranging from social interactions to breast tissue; 2) potential pathways for breast cancer prevention interventions; and 3) translation of research findings into multilevel intervention strategies in community settings. The proposed research and training will provide me with the necessary skills and interdisciplinary and community collaborations needed to study and address cancer health disparities. Upstream >>>>>>>>>>>>>>>>>>>>>>>>>>>Downstream Structural >Interpersonal>Individual>System>Tissue>Cellular Social Conditions & Relationships Socioeconomic status, race; Social integration; Social support Risk Behaviors Physical Biological Mechanisms Metabolic Risk Factors (e.g., obesity, lipids,blood activity; Diet Figure 1. Conceptual Model pressure) Breast Cancer Outcomes Cancer diagnosis; Breast Density